Rhode Island IDeA Network of Biomedical Research Excellence

Project Summary for Administrative Core
The overarching goal of Rhode Island-IDeA Network of Biomedical Research Excellence (RI-INBRE) is to
improve institutional capacity for biomedical research excellence and student experiential training in the State of
Rhode Island. The University of Rhode Island (URI) is the lead institution for RI-INBRE and will serve as the
major network administrative and assessment hub. The Administrative Core is one of the five cores of the
program. The major goal of the Administrative Core is to strategically oversee the development of an inclusive,
productive, and collaborative biomedical research environment in the State of Rhode Island. By achieving this
goal, RI-INBRE will promote the creation of a dynamic and well-trained biomedical workforce and act as a
catalyst for investment and entrepreneurship in the biomedical sciences in Rhode Island. Our five-year strategic
plan for this renewal application, which is guided by the achievements and lessons learned in the previous
funding period, is to: provide diverse career development opportunities for investigators; manage the functions
of the External Advisory Committee (EAC), the Steering Committee (SC), the Scientific Executive Committee
(SEC), and the Faculty Development Mentoring Committee; create a pipeline of trained individuals for careers
in the cancer, neuroscience, and environmental health sciences thematic areas; and implement and oversee
comprehensive external survey and assessment.

Public health relevance
Narrative for Administrative Core is not applicable.